Social influences on choices in adolescent substance use

PROJECT SUMMARY / ABSTRACT
In the United States, substance use behaviors contribute to the leading causes of mortality and morbidity of
adolescents, and are associated with approximately $60 billion in economic costs per year. Negative peer
influence is a major environmental risk factor for early initiation of substance use and other risky behaviors.
However, group-based interventions and positive social supports are also beneficial for successful cessation of
substance use and addictive behaviors. Thus, social influences can contribute to adaptive or maladaptive
decision-making and depend on the context and nature of the influence. Despite the strong contribution of
peer influence to individuals' risky (or safe) decision-making, the mechanistic processes underlying
susceptibility and resilience to social influence have received limited investigation.
Here, we combine a longitudinal cohort design, functional neuroimaging, novel behavioral economic
paradigms, and a model-based approach to examine whether substance use, and changes in substance use, are
related to individual differences in two mechanisms by which social information influences risky decision-
making (Aims 1 & 2). To test the extent to which changes in substance use may also impact susceptibility to
social influence, we will further examine reciprocal effects of substance use on the mechanisms of social
influence over time (Aim 3). Our broad hypothesis is that biases in neural and behavioral processing of
information from social others contribute to the development of substance use behaviors in adolescents and
may explain why social others have an unusually large impact on certain adolescents' decisions to engage in
substance use.

Public health relevance
PROJECT NARRATIVE In the United States, substance use behaviors contribute to the leading causes of mortality and morbidity of adolescents, and are associated with approximately $60 billion in economic costs per year. Influence from social peers can contribute to adaptive or maladaptive decision-making in adolescents and depends on the context and nature of the peers. Here, we combine a longitudinal cohort design, functional neuroimaging, novel behavioral economic paradigms, and a model-based approach to examine how social information influences decision processes leading adolescents to make risky or safe choices, including substance use behaviors.